American Urological Association (AUA) Urologic Oncology Research Symposium on "Implementation Science: Translating Clinical Studies into Practice"

2024 AUA OFFICE OF RESEARCH UROLOGIC ONCOLOGY RESEARCH SYMPOSIUM
“Implementation Science: Translating Clinical Studies into Practice”
PROJECT SUMMARY/ABSTRACT
This application requests support for our annual Urologic Oncology Research Symposium during the
Annual Meeting of the American Urological Association (AUA), to be held on Friday, May 3, 2024, 1:00 pm
– 5:00 pm in San Antonio, TX. The 2024 topic, “Implementation Science: Translating Clinical Studies into
Practice,” will bring together pioneers in implementation science and clinical trials in urology to educate and
foster interaction between urologists, other physicians, and researchers who manage and/or study
malignant urological disorders.
The symposium will bring the latest research advancements in implementation science and clinical trials in
urology to the world’s largest gathering of national and international, private and academic practice, and
physician scientists and researchers at all career stages as well as have immediate applicability to
malignant urology research. Early-career investigators will comprise a significant proportion of the
symposium presenters and audience and the poster session will provide additional scientific discourse.
Proposed session topics include:
1. “Improving the conduct and efficiency of clinical trials with implementation science.”
2. “Implementing risk-aligned bladder cancer surveillance.”
3. “Improving reproductive care with implementation science”
4. “Optimizing smoking cessation treatment for patients with bladder cancer.”
5. “Facilitating evidence-based surgical practice”
The Principal Investigator for this project is Christine Riordan, PhD, LCSW-C, AUA Director of Research, and
the Program Planning Chairs are Shellie D. Ellis, MA, PhD, Associate Professor, University of Kansas Medical
Center, and Ted Skolarus, MD, MPH, FACS, Professor of Surgery, University of Chicago. All faculty possess
exemplary records in NIH research funding, mentoring trainees, and planning urology research education.
The Program Chairs prioritized consideration of racial, ethnic, gender/gender identity, sexual orientation,
nationality, cultural, religious, age, (dis)ability, career stage, and socioeconomic backgrounds in
accordance with the Diversity, Equity, and Inclusion Statement of the Research Education Conferences,
and Communications Committee (RECCC). Support for this symposium will provide travel awards for
approximately 20 trainees and early-career investigators.

Public health relevance
2024 AUA OFFICE OF RESEARCH UROLOGIC ONCOLOGY RESEARCH SYMPOSIUM “Implementation Science: Translating Clinical Studies into Practice” PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE STATEMENT Understanding implementation science in benign and malignant urologic disease is crucial to advancing urologic research and improving clinical care, and it is essential that the urology community, especially trainees, early-career physician-scientists, and researchers be provided with accessible opportunities to gain understanding of new knowledge and significant recent advances in these fields and leverage it towards improvements for patient diagnosis and treatment. The goal of the 2024 AUA Urologic Oncology Research Symposium is to bring together pioneers in implementation science to educate and foster interaction between urologists, other physicians, and researchers. The uniqueness of the 2024 Urologic Oncology Research Symposium at the AUA Annual Meeting is not only that it brings the latest advancements in research to the world’s largest gathering of urologists and urology researchers, but also that the Program Chairs prioritized consideration of racial, ethnic, gender/gender identity, sexual orientation, nationality, cultural, religious, age, (dis)ability, career stage, and socioeconomic backgrounds in accordance with the Diversity, Equity, and Inclusion Statement of the AUA Office of Research: Research Education Conferences, and Communications Committee (RECCC).